VET-LIRN Network capacity building projects..

PROJECT SUMMARY
Instructions:
The summary is limited to 250 words. The names and affiliated organizations of all Project Directors/Principal Investigators (PD/PI) should be listed in
addition to the title of the project. The summary should be a self-contained, specific description of the activity to be undertaken and should focus on: overall
project goal(s) and supporting objectives; plans to accomplish project goal(s); and relevance of the project to the goals of the program. The importance of a
concise, informative Project Summary cannot be overemphasized.
Title: Vet-LIRN Network Capacity-Building Projects
PD: Tewari, Deepanker Institution: Pennsylvania Department of Agriculture
Pennsylvania Veterinary Laboratory
Pennsylvania Veterinary Laboratory
CO-PD: PD/PI 3 Name (Last, First, MI) Institution:
CO-PD: PD/PI 4 Name (Last, First, MI) Institution:
CO-PD: PD/PI 5 Name (Last, First, MI) Institution:
CO-PD: PD/PI 6 Name (Last, First, MI) Institution:
CO-PD: PD/PI 7 Name (Last, First, MI) Institution:
Project will help with the following objectives
.
Procurement of supplies and maintenance needed for next generation testing
efforts
This file MUST be converted to PDF prior to attachment in the electronic application package.

Public health relevance
Project narrative 1. Procurement of supplies needed for WGS testing efforts or method improvement. The laboratory plans to build and expand expertise and capacity in the emerging whole genome sequencing (WGS) technology that can be used for epidemiologic tracebacks and case investigations related Vet-LIRN activities. The laboratory plans to work with the FDA GenomeTrakr Network to develop technical knowhow in sequencing of bacterial whole genomes and data analysis for pathogen identification, phylogenetic analysis and identification of virulence genes and antimicrobial resistance genes. The laboratory plans to participate in the WGS proficiency test offered by the GenomeTrakr Network. The laboratory currently has Illumina MiSeq platform and Oxford Nanopore MinION Sequencing platform. Funding for training, equipment maintenance, IT equipment and software for data analysis, reagents and consumables will help with validation and testing of the platforms for investigations related to LIRN